Advanced environmental cage monitoring to improve facility operations, animal welfare, and research outcomes for UCLA’s rodent Behavioral Testing Core users.

Project Summary/Abstract
The University of California, Los Angeles (UCLA) rodent Behavioral Testing Core (BTC) in collaboration
with the Division of Laboratory Animal Medicine (DLAM) are seeking to convert the current static,
unventilated cage racks to Tecniplast’s Digital Ventilated Cage System (DVC). This system leverages
the power of machine learning to remotely monitor, record, and interpret numerous external
environmental factors, including temperature, noise, vibration, light, motion, as well as in-cage
information, including animal location and activity, animal fighting and aggression, early pathology
detection, changes in urination, cage sanitation, and food and water status. Enhancing the reliability
and reproducibility of preclinical rodent research is paramount for translation of novel therapeutics into
realized human treatments. Computational analysis has identified both environmental variables (e.g.,
temperature, humidity, noise, etc.) and human exposure as significant factors contributing to
inconsistencies in research outcomes. The goal of this proposal is to modernize current rodent housing
and enhance the reproducibility and rigor of preclinical studies performed by the rodent Behavioral
Testing Core (BTC) and collaborators by 1) providing a more efficient, stable, and controlled vivarium
environment, 2) improving animal welfare and study-related outcomes with real-time tracking and
alerts, and 3) collecting critical extrinsic information to quantify their impact on the biological and
behavioral output of the housed mice. Upgrading to the DVC system will significantly enhance
operational efficiency by decreasing required cage changes, thus lowering the necessary human
exposure. With remote monitoring, we aim to improve the health status of mice through the automatic
detection of aberrant behaviors (e.g., sickness, fighting), thereby allowing earlier intervention for
improved health outcomes. Finally, automated collection of extrinsic information will significantly
enhance the rigor of BTC client experiments by providing confirmation of carefully controlled
environments, as well as novel metrics for behavioral analysis, including activity levels and circadian
rhythms, data previously unavailable to Core users. Collectively, we expect these upgrades to
significantly enhance the reliability and replicability of data produced in the BTC. Additionally, the DVC
system will have a significant impact on researchers across the UCLA campus. The BTC has designed
and implemented research studies with laboratories from over thirty different departments from four
different schools across UCLA. In the last year, BTC projects have been funded by grants from
numerous NIH institutions, including NINDS, NIMH, NIDCR, NIDA, NCI, and NIA. The BTC resides
within the Psychology department and shares vivarium space with other behavioral researchers, who
will also have access to data generated with the DVC system and will benefit from these upgrades.

Public health relevance
Project Narrative This proposal will have a significant impact on public health, as it seeks to modernize and upgrade rodent housing for mice involved in preclinical research studies that are critical for the discovery of new therapies for human health and disease. Upgrading rodent housing will facilitate better research outcomes by decreasing rodent stress and improving their overall wellbeing, as well as provide novel metrics for tracking mice, and it will improve facility operations by utilizing numerous automated systems to monitor cage status and environmental conditions.